Testing competing models of the computational role of dopamine in hallucinations

Project Summary:
Hallucinations are common in clinical and nonclinical groups, can be difficult to treat, and often predict worsening
functionality. The poor efficacy and severe side effects of current treatments are in part a consequence of our
immature understanding of the mechanisms that cause hallucinations. Excess striatal dopamine release has
been causally implicated in the development and severity of hallucinations but the precise circuits and cognitive
processes that link this neurochemical alteration to false perception remain unclear. Evidence from the basic
neuroscience literature has inspired competing theories about how excess striatal dopamine drives
hallucinations. Specifically, reward and perceptual hypotheses of hallucinations have emerged, but they have
yet to be directly tested in a falsifiable framework. Identifying which of these hypothesized mechanisms drives
hallucinations is critically important given that reward and perceptual learning are facilitated by distinct
dopaminergic basal circuits each of which may provide a separate treatment target. We have developed a
mathematical framework that formalizes these hypotheses with biologically grounded computational models and
generated falsifiable predictions about how alterations in either perceptual or reward learning could drive
hallucinations.
Here, we will rigorously test the neural and behavioral predictions of these models using a novel fMRI-compatible
auditory signal-detection task and a validated proxy measure for midbrain dopamine function. In Aim 1, we will
evaluate participant perceptual and reward learning and the relationship with hallucination proneness. In Aim 2,
we will identify the neural circuits that support reward and perceptual learning during the task. In Aim 3, we will
use a validated proxy measure of dopamine function to dissociate the specific subcircuits driving alterations in
learning. Overall, the proposed study aims to bridge the explanatory gap between our understanding of the
neurochemistry and phenomenology of hallucinations. Critically, this could promote the identification of
individualized treatment targets that are not only more effective but have more limited side effects. This proposal
will also support my training in state-of-the-art computational modeling and neuroimaging approaches and
promote my development as an independent researcher in the field of computational psychiatry.

Public health relevance
Project Narrative: Hallucinations are widespread and debilitating but current treatments often fail to improve symptoms and cause severe side effects that limit treatment adherence. We will use a novel fMRI-compatible auditory task, computational modeling, and a validated proxy measure for midbrain dopamine function to identify the neurocognitive mechanisms and circuitry underlying hallucination proneness in the general population. This approach will allow us measure circuit-specific alterations driving false perceptions and could prompt individualized treatment strategies that may not only be more effective but could also limit problematic side effects and improve quality of life.